Placental cell-and size-specific extracellular vesicle RNA cargo analysis throughout human gestation

The contributions of the placenta to normal pregnancy physiology, as well as the pathophysiology of
preterm birth, fetal growth disruption, and preeclampsia, are well-recognized, but we cannot predict, prevent, or
adequately treat these common complications that affect approximately 10% of human pregnancies.
A major challenge to understanding placental development and function using in vivo real-time
assessments across gestation (e.g. goal of the Human Placental Project and PAR-22-236) is limited access
to longitudinal tissue samples throughout human pregnancy. Others have shown that placental extracellular
vesicle (EV) concentrations and contents in maternal plasma may be related to placental development and
function, which suggests that placental EVs may be a promising biological resource for in vivo studies. EVs
include a range of submicron particles, including small exosomes, larger microvesicles, and cell fragments
undergoing necrosis and apoptosis. EVs contain a variety of RNA species (including microRNAs) that provide
insights into their source and potential function (e.g. regulating angiogenesis). Methods like density gradient
ultracentrifugation, size exclusion chromatography, and affinity capture provide a heterogeneous mixture of
EVs from a variety of cell sources and a variety of EV sizes. These methodological shortcomings have limited
characterization of placental-specific EVs by failing to precisely characterize their source and cargo.
As a result, there is an immediate need for a novel approach to image, count, and isolate cell- and size-
specific EVs from maternal blood across gestation to monitor placental development and function. In
collaboration with BD Biosciences, we have developed a multiplex high resolution nanoscale flow cytometry
method to image, count, isolate and validate placental cell- and size-specific EVs. Importantly, this novel
technology enables us to study placental EVs from syncytiotrophoblasts, extravillous trophoblasts, and
endovascular trophoblasts that likely have different contents and functions during pregnancy. Moreover, we
can compare the content of these sorted EVs with sorted 100nm liposomes spiked into the same plasma to
control for background contamination inherent to any EV isolation method. We have also developed a novel
242 monoclonal antibody multiplex design with 3-4 antibodies (3/4-colors)/well in a 96-well plate design to
address the entire maternal EV-biome throughout gestation. We hypothesize that nanoFACS sorting
technology and our new EV-biome design will bring much needed precision and accuracy to the imaging,
counting, and isolation of cell- and size-specific placental EV analysis across gestation, which will help us to
better understand the role of EVs in placental development and function in vivo. In this project, we will test for
differences in cell- and size-specific EV profiles in maternal plasma, which have already been banked from
uncomplicated and complicated pregnancies collected at 12, 24, and 32 weeks’ gestation that are linked to
published study subject metrics and unique characterization of uteroplacental blood flow by T2*MRI.

Public health relevance
Placental extracellular vesicle (EV) plasma concentrations and RNA cargo may provide insights into placental development and function in vivo, in real-time, across human gestation. Currently available technologies to study EVs are limited by heterogeneous mixtures of EVs and artifacts inherent in EV isolation. We have developed a nanoscale flow cytometry technology that can image, count, and isolate cell- and size-specific placental EVs, which we will employ using already banked maternal plasma samples from 12, 24, and 32 weeks’ gestation; our innovative approach will lead to more accurate EV profiling, quantitation, and content.